AHRQ Mentored Clinical Scientist Research Career Development Award (K08): Maya Dewan

PROJECT ABSTRACT
Pediatric in-hospital cardiac arrest most commonly occurs in the pediatric intensive care unit and carries
extensive morbidity and mortality. This proposal describes a 5-year research and training program that will
allow Dr. Maya Dewan to address the prevention of pediatric cardiac arrest through clinical decision support
and implementation science. Having completed fellowship training in pediatric critical care medicine and
building on a background of improvement science, epidemiology/biostatistics, and clinical informatics the
applicant seeks to develop new knowledge and skills to use design informed clinical decision support and
implementation science to improve the care and outcomes for critically ill children.
This application seeks to address prevention of pediatric cardiac arrest. Prevention of cardiac arrest events is
feasible because children often display warning signs prior to deterioration. The applicant’s preliminary studies
demonstrate that prediction of pediatric patients at high-risk for clinical deterioration is feasible. The specific
aims of the proposed investigations are to: 1) To prospectively validate the PICU Warning Tool to predict
clinical deterioration, 2) To evaluate the impact on prediction and situational awareness of adding manual high-
risk criteria to the automated PICU Warning Tool, 3) To elucidate factors in system design that will improve
implementation of the PICU Warning Tool.
This work is significant as it focuses on the development and implementation of an effective health information
technology intervention to improve health care quality. It leverages the capability of health information
technology to improve quality, efficiency, and effectiveness of care for the highest risk pediatric patients. While
this training grant focuses on the implementation of health IT in improvement science work, it also addresses
the research areas of design, use, and impact on outcomes. Through a Type 1 effectiveness-implementation
hybrid design, Dr. Dewan will identify barriers and facilitators to implementation to facilitate a successful
translation from an academic research tool to a well implemented clinical decision support tool suitable for
routine practice.

Public health relevance
PROJECT NARRATIVE Pediatric in-hospital cardiac arrest most commonly occurs in pediatric intensive care units and carries extensive morbidity and mortality making prevention the best approach. Prevention of cardiac arrest events is feasible because children often display warning signs prior to deterioration. This application seeks to address prevention of pediatric in-hospital cardiac arrest through clinical decision support and implementation science.